A novel instrument for continuous blood pressure monitoring

Project Summary/Abstract
Problem High blood pressure (BP) is a substantial public health problem that affects 45% of adults (75% of
individuals over age 65) and is a leading cause of excess cardiovascular morbidity and mortality. BP monitoring
has high diagnostic and prognostic value as an important marker of cardiovascular disease. Static BP snapshots,
which are typically obtained via sphygmomanometry during doctor’s office visits, have documented reliability
issues, including “white-coat” hypertension and poor technique. Auscultatory or oscillometric cuff-based ambu-
latory BP monitors (ABPMs) that can be worn in home settings and provide regular automated measurements
over 24-hour periods have seen widespread adoption. However, these devices also suffer from poor reliability
because measurements are seldom performed according to the specified guidelines even with training (e.g.,
seated, feet not crossed, arm cuff maintained at heart level, etc.). They also yield only intermittent measure-
ments (potentially missing important BP events), worsen sleep quality due to their intrusiveness, confound BP
measurements due to autonomic response to cuff inflations, and are obtrusive and uncomfortable.
Solution The proposed Blood Pressure Sage (BP-SAGE ) system will be a novel, reliable, easy-to-use, and
comfortable (non-cuff-based) continuous ABPM (cABPM) that can operate 24/7, even during activities of
daily living (ADL) and sleep without disturbing or requiring any action from the wearer, and without imposing
stringent measurement guidelines.
This new class of BP monitor will be an important addition to clinical practice, accurately and unobtrusively
assessing individuals with established or suspected hypertension, even during movement and without uncom-
fortable cuff inflations. BP-SAGE will provide accurate BP estimates without restricting users’ mobility, body
postures, or arm elevations. The beat-to-beat BP estimates may be used directly or averaged over arbitrary
intervals (e.g., to reproduce conventional ABPM results).
The Phase I effort will demonstrate proof-of-concept and feasibility for the BP-SAGE methodology via rigorous
evaluation in both healthy and hypertensive subjects. In particular, BP-SAGE systolic, diastolic, and mean arterial
BP estimates will be obtained during rest and at different BP levels and compared to criterion BP measurements
obtained using a laboratory-grade continuous noninvasive BP (cNIBP) monitor. As a true pulse transit time
(PTT)-based technique, and based on the proposed novel modeling approach that also accounts for variations in
vasomotor tone, BP-SAGE will obviate the need for repeated calibrations associated with traditional pulse arrival
time (PAT)-based methods. BP-SAGE software will automatically generate clear, interpretive reports that meet
international standards and include summary data to simplify interpretation by clinicians. BP-SAGE will fulfill
the need for an ergonomic, accurate, reliable, and low-cost continuous BP monitoring for use in healthcare and
clinical research.

Public health relevance
Project Narrative BP-SAGE technology will be useful across all ages clinically, in daily life, and in research for cardiovascular disease prevention and management. In addition to a complete 24-hour BP profile (during sleep, wake, ambulation, and ADLs), BP-SAGE will provide information on abnormal patterns and indices of BP and other hemodynamic parameters (e.g., heart rate, ambulatory arterial stiffness, BP variability, etc.). BP-SAGE will also have consid- erable utility in guiding therapeutic interventions and in judging their efficacy. Significant advantages of the proposed BP-SAGE technology are that: (1) recalibration is not required over measurement periods; (2) patients have freedom of movement and activity, and they are not constrained by arm cuffs, pressure tubing, wires, and waist monitors that are intrusive, interfering, and conspicuous; (3) systolic, diastolic, and mean arterial BP are measured continuously on a beat-to-beat basis; and (4) no action is required by the user; measurements are obtained automatically by the system. These features are critical to ensure that significant cardiovascular events are not missed and to enable telemonitoring of patients’ in home settings, similar to present-day Holter ECG telemonitoring. BP-SAGE will be the only low-cost, non-cuff-based wireless BP monitor on the market; it will usher in a new era of affordable and practical continuous ambulatory blood pressure monitoring (cABPM).